NCORP of the Carolinas (Greenville Health System NCORP)

PROJECT SUMMARY/ABSTRACT
NCORP of the Carolinas is positioned to provide a sustained, powerful influence on cancer care through
research in the community setting. The investigators commit to shift current research and clinical practice
paradigms based on the outcomes of NCTN research. The goals of NCORP of the Carolinas are as follows: to
engage community oncologists and other medical specialists in NCTN cancer control, prevention, and care
delivery research, as well as quality-of-life studies embedded within treatment and imaging studies; to offer the
adult and pediatric communities cancer control, prevention, treatment and care delivery trial opportunities; to
engage, recruit and enroll participants from the community inclusive of minorities, underrepresented, and
underserved populations; to ensure all eligible participants are offered the opportunity for biospecimen
collections; to inform the community of advances made through research; to assure accurate and timely data
submission and protocol compliance; to participate with the respective research bases in concept development
and identification of study opportunities for disparities in the community; to enhance and improve involvement
of patient advocates by including advocates in research concepts and recruitment strategies; and to mentor
new investigators, partners, and research staff.
The expansion of GHS (Upstate) and Palmetto Health System (Midlands) into the SC Health Company and the
joint facilities and resources more than adequately support future growth and accruals through NCORP of the
Carolinas cancer initiatives. More than 300 clinical trials are active at any given time at the GHS Cancer
Institute and include Phase I, Phase II, Phase III treatment trials, prevention trials, symptom management
trials, and quality of life trials, all of which provide patients with the latest technology throughout their cancer
care continuum. Research offerings across the spectrum from prevention to palliative care ensure patients
receive the best care possible. New research initiatives include state-of-the-art genetic mapping for molecular
targets that enable patients to stay in the catchment area for cutting-edge treatment tailored specifically to
them. Data management is important to both the clinical and business management of cancer services.
NCORP of the Carolinas is poised to succeed in all aspects of the NCORP mission and contribute
meaningfully to the NCORP goals by engaging patients and conducting the anticipated range of clinical trials
and human subject studies.

Public health relevance
PROJECT NARRATIVE A robust clinical trials program is relevant to achieving advances in addressing unmet needs of cancer patients in the realm of treatment, cancer control, prevention, and care delivery. NCORP of the Carolinas is positioned to provide a sustained, powerful influence on cancer care through research in the community setting.